Vibrio cholerae c-diGMP signaling: Motile to biofilm transition and transmission

PROJECT SUMMARY
The signaling nucleotide cyclic dimeric guanosine monophosphate (c-diGMP) is broadly conserved in bacteria
and is a key regulator of central cellular processes including motility, biofilm formation, and virulence. Our
understanding of how c-diGMP controls biofilm formation, the environmental signals modulating c-diGMP levels
and biofilm formation, and the dynamics and consequences of c-diGMP signaling during infection remains
limited. This proposal aims to fill critical gaps in our understanding of how c-diGMP signaling and biofilm
formation control the infection cycle of Vibrio cholerae, which causes the disease cholera, an important global
public health problem. We will address these information gaps through two specific aims. 1) Determine
mechanisms of signal sensing and response in c-diGMP signaling networks; and 2) Analysis of c-diGMP
signaling during infection. Under the first aim, the molecular mechanism(s) of activation of key c-diGMP signaling
proteins will be determined using structural and ligand-binding studies. The down-stream c-diGMP signaling
pathways initiated upon surface attachment will be analyzed by employing microscopy-based community
tracking methods to measure motility, division, and c-diGMP levels. The mechanism by which specific key c-
diGMP signaling proteins act to regulate surface attachment and biofilm matrix production will be determined
using a combination of genetic and biochemical approaches. Under the second aim, we will analyze key c-diGMP
signaling pathways that are activated during infection. This part of the proposal will track and examine the
mechanisms underlying temporal and spatial dynamics of c-diGMP production and virulence gene regulation
during infection using state-of-the-art imaging tools and novel c-diGMP sensors. The proposed work will greatly
advance our understanding of how c-diGMP signaling operates, identify the inputs that influence c-diGMP
production and degradation, and unveil the biological consequences of c-diGMP signaling in vivo. This research
promises molecular and mechanistic insights that will allow us to devise ways to control c-diGMP signal
transduction pathways governing motility, biofilm formation, and virulence, ultimately identifying potential
therapeutic or preventive targets that can be exploited for preventive measures against cholera.

Public health relevance
PROJECT NARRATIVE Vibrio cholerae, the causative agent of cholera, remains a major global public health problem. In many bacteria including V. cholerae, the signaling molecule, c-diGMP, acts through ill-defined pathways to regulate bacterial motility, biofilm formation, and virulence. This proposal will determine the mechanisms and consequences of c- diGMP signaling pathways on the V. cholerae infection cycle since elucidating these signaling pathways could support the development of novel therapeutics that attenuate c-di-GMP signaling in Vibrio and other disease- causing microorganisms.